Police Pathways to Addiction Treatment, Health, and Safety: The Police PATHS Study

Project Summary In the U.S., police officers encounter people who use drugs (PWUD) millions of times per year. Often, these encounters arise from unlawful behavior associated with problematic substance use, resulting in arrests that increase subsequent overdose risk and diminish other health outcomes. As an alternative to arrest on misdemeanor charges, police-assisted diversion (PAD) links PWUD with treatment and services, especially medications for opioid use disorder, offering the potential to reduce overdose, protect health, and address the addiction-related problems that can motivate unlawful behavior. To leverage this potential, police agencies across the nation have implemented PAD, while opioid settlement funds provide the opportunity for PAD’s expansion. Yet, gaps in our knowledge about PAD prevent agencies from maximizing its impact. As there has yet to be a rigorous study of its effect on health outcomes, jurisdictions cannot be sure how its costs compare to arrest as usual, and there is little understanding of how to effectively implement the intervention. This project will investigate those gaps in two large U.S. cities facing especially acute and persistent overdose crises: Philadelphia, where PAD has operated since 2017, and Baltimore, where it faced implementation challenges that made it unsustainable. Employing the Exploration, Preparation, Implementation, Sustainment framework, Aim 1 will use semi-structured interviews of Baltimore and Philadelphia police (n=25 in each city), and Philadelphia PAD clients (n=25) and providers (n=25) to construct retrospective implementation research logic models for each site. The models will array the causal pathways—and expose the causal gaps—that link implementation determinants, de-facto strategies, and mechanisms to outcomes including feasibility, acceptability, appropriateness, fidelity, and sustainability. Aim 2 will evaluate the causal effects of PAD in Philadelphia on access to medications for opioid use disorder and its health outcomes (e.g., overdose, hospitalization for injection-related infections) using a quasi-experimental analysis of linked administrative data from thousands of PWUD who did and did not receive PAD. Aim 3 will assess the cost-effectiveness of PAD compared to criminal justice processing as usual by using data from PAD and non-PAD individuals to parameterize an economic model and estimate the mean incremental cost effectiveness ratio of PAD. The project will yield a comprehensive understanding of PAD, and provide novel data about the decomposition of a public health intervention in Baltimore’s challenging setting. It will improve PAD in Philadelphia and assist Baltimore in an anticipated re-implementation. The Law Enforcement Assisted Diversion National Support Bureau will ensure the project’s findings are used by practitioners to implement and sustain PAD across the U.S., and the project’s logic model will provide the means for police and researchers to conduct PAD implementation in a rigorous and methodical way. Results will also provide the basis for implementation and effectiveness trials of PAD in other settings that test the determinants and strategies observed to have had the greatest impact in the cities here. This study is part of the NIH’s Helping to End Addiction Long-term (HEAL) initiative to speed scientific solutions to the national opioid public health crisis. The NIH HEAL Initiative bolsters research across NIH to improve treatment for opioid misuse and addiction.

Public health relevance
Public Health Relevance Statement Amid the most severe overdose crisis in US history, people who use drugs encounter police millions of times a year, providing a critical opportunity to link them with effective treatment and services as an alternative to arrest and prosecution for minor charges. To fill critical gaps in our knowledge about the cost, health impacts, and successful implementation of these police-assisted diversion programs, this project will study the programs designed to provide such linkages to care in two US cities with especially acute and persistent overdose crises: Philadelphia, and Baltimore. We will characterize the implementation of these programs in both cities, and determine the cost effectiveness and health outcomes of police-assisted diversion in Philadelphia, with the potential of informing the practices of police and health care providers nationwide. SPECIFIC AIMS As the U.S. faces the most severe drug overdose crisis in its history, linking the individuals at greatest risk of drug-related harms with interventions that can reduce those harms remains a struggle. However, these hard-to- reach populations are consistently among the most likely to encounter police. Nearly 85% of people who use drugs (PWUD) report a history of arrest, and a third report a recent police encounter. In millions of cases these encounters result in discretionary, low-level arrests that result from or coincide with challenges such as housing instability, economic precarity, and high-risk substance use. While court, jail, and prison-based interventions may offer PWUD health services downstream, police encounters are an opportunity to provide a comparatively large population of at-risk PWUD with an immediate connection to community-based services. Police-assisted diversion (PAD), where arrestees on minor charges are linked with care rather than booked, represents an intervention for PWUD who are otherwise difficult to engage, and has the potential to reduce exposure to prolonged entanglements with the criminal justice system that can threaten their health. As an intervention to align public health and safety, PAD offers strong face-validity: arrest and booking are not therapeutic, while PAD offers linkage to health services including effective addiction treatment, such as medications for opioid use disorder (MOUD), which can reduce mortality and recidivism alike. Despite resources allocated towards PAD nationally, there remains a critical gap in knowledge about its impact on health and economic outcomes, as well as contextual determinants that facilitate or hinder successful implementation. Two large US cities exemplify the need for this knowledge: Philadelphia and Baltimore, which serve as the settings for this project. Facing overdose crises that have proven to be especially persistent and acute, both cities began implementing PAD in 2017. In Philadelphia, PAD has since expanded into a citywide network of providers and community-based organizations serving thousands of PWUD, but there have been no rigorous evaluations of its health or cost outcomes to date. In Baltimore, challenges encountered following PAD’s pilot phase prevented scale-up, providing a novel opportunity to study the deconstruction of a diversion program. The specific aims of this study will provide insights critical to the implementation of PAD programs across U.S. police departments, informing interventions to reduce overdose fatalities and their disparities nationwide. Specific Aim 1: Characterize the implementation determinants, strategies, mechanisms, and outcomes of PAD in Philadelphia and Baltimore. Qualitative interviews of purposively sampled police officials in both cities (n=25 each) will be complemented by interviews of PAD clients (n=25) and purposively sampled providers in Philadelphia (n=25). Data collection will be structured by the Exploration, Preparation, Implementation, Sustainment framework. Implementation strategies will be mapped onto the Expert Recommendations for Implementing Change where appropriate and used in conjunction with identified determinants to describe how mechanisms influenced outcomes, especially feasibility, acceptability, appropriateness, and sustainability. Specific Aim 2: Estimate the effect of Philadelphia’s PAD program on health outcomes of PWUD. Using integrated criminal justice and administrative medical data, we will estimate the causal effects of PAD on receipt of MOUD (primary outcome), hospitalizations for drug-related harms (e.g., skin and soft tissue infections), and all-cause and overdose mortality (secondary outcomes) from 2023-2026. Outcomes will be compared between individuals referred to PAD and matched controls using an inverse probability weighted marginal structural model approach. We hypothesize PWUD referred to PAD will be more likely to receive MOUD within 30 days and have significantly reduced 12-month hospitalizations and all-cause and overdose mortality, compared to control participants who were arrested and processed by the justice system as usual. Specific Aim 3: Determine the cost-effectiveness of PAD compared to arrest processing as usual. We will empirically derive unit costs of PAD referrals and use data from our cohorts of PAD and non-PAD individuals to parameterize a health state transition model. We will estimate the mean incremental cost effectiveness ratio of PAD versus arrest to assess the value for money of PAD and inform evidence-based decision-making. The construction of retrospective implementation research logic models for each site will synthesize the project’s analyses across aims, illuminating intended and de facto causal relationships. The models will elucidate PAD’s real-world effect on substance use-related health outcomes, implementation factors that bear on its success, and the comparative value of PAD as an investment in evidence-based policy. This proposal is directly responsive to the ONDCP’s 2025 strategic priorities, and NIDA’s RFA-DA-25-062, which has the goal of funding research to “examine interventions, practices, or implementation strategies that are widely used, but for which there is limited evidence... including law enforcement diversion and deflection.” Through collaboration with the Law Enforcement Assisted Diversion National Support Bureau, findings will be used by practitioners to implement and sustain PAD nationally, informed by evidence about its comparative costs and benefits. This study will also provide the basis for a future hybrid implementation and effectiveness trial of PAD to test the determinants and strategies observed to have had the greatest impact on PAD’s implementation and its health outcomes among PWUD.